MatTrack: The impact of preconception maternal weight trajectories on maternal, pregnancy, and child outcomes

PROJECT SUMMARY/ABSTRACT:
Elevated body mass index (BMI) at pregnancy onset and excessive gestational weight gain (GWG) are
consistently associated with adverse pregnancy and child outcomes. Diet and lifestyle interventions during
pregnancy have had limited success in reducing GWG or postpartum weight retention (PPWR), with no
improvement in perinatal or childhood outcomes. Therefore, multiple organizations recommend that women
attain a healthy weight before pregnancy. However, the benefit and risks for mother and child extending
beyond delivery, optimal timing of preconception weight change, and how risks and benefits of
preconception weight loss differ across clinical subgroups are currently unknown. Our preliminary data
suggest that the weight trajectories upon which women enter pregnancy (loss, maintenance, or gain) may
impact the hormonal milieu of early pregnancy as well as the amount of GWG and PPWR. The objective of
this study is to examine the impact of weight trajectories in the immediate preconception period (within 2
years before pregnancy) on GWG, PPWR, pregnancy outcomes, and child growth. Our central hypothesis is
that preconception weight change toward a normal BMI reduces risk of adverse pregnancy and birth
outcomes by improving pre-pregnancy weight status, but may increase GWG, which then increases risks of
outcomes sensitive to GWG (PPWR, large for gestational age, infant weight gain, child BMI). We further
hypothesize that these associations are strongest among women with more extreme BMI and for more rapid
weight change occurring closer to pregnancy. To test this hypothesis, we will leverage a transcontinental
clinical data warehouse spanning almost 20 years with the weight and pregnancy data of more than 130,000
racially, ethnically, and socioeconomically diverse women, and weight and length/height data of their children
through age 3 years. We will determine the relationship between maternal preconception weight trajectories
and GWG (total and trimester-specific) and PPWR at 6 weeks and 12 months postpartum, risk of adverse
pregnancy outcomes (gestational diabetes, gestational hypertension/preeclampsia, and cesarean section)
and child outcomes (preterm birth, size for gestational age at birth, infant growth trajectory, and BMI at 3
years of age); and the degree to which these associations are mediated by GWG. For each aim, we will test
the hypotheses within pre-pregnancy BMI classifications, high risk clinical subgroups (e.g., pre-existing
diabetes, hypertension) and racial/ethnic subgroups. Our findings will inform preconception weight
management recommendations and shape the future of preconception and antenatal weight management
research.

Public health relevance
PROJECT NARRATIVE Women who are under- or overweight at the start of their pregnancy are at higher risk of problems during pregnancy and birth. Doctors recommend that women gain or lose weight so they will be at a healthy weight before getting pregnant, but our research shows that changes in weight right before pregnancy might make it harder for women to gain a healthy amount of weight while they are pregnant. In this study, we will use medical record data from more than 130,000 women and their children to test how different patterns of weight change before and during pregnancy affect the health of women and their children.